DEVELOPMENT OF DATA RESOURCES FOR NEUROEPIDEMIOLOGY

To develop 1) a registry of hospitalized patients with neurologic disease in a well-defined population of 3.5 million people, and 2) resources for case-control studies of neurologic diseases using uniform methods of data collection.